Understanding the skeleton in Down Syndrome

SUMMARY/ABSTRACT
This new R01 application entitled “Understanding bone mass in Down Syndrome” is focused on determining
the cellular mechanism for the low bone turnover we have identified in people and mice with Down Syndrome
(DS), and on characterizing fracture healing responses in different DS mouse models to gain insight into how
to better target fracture healing in the DS population with increased propensity to fracture. This proposal will
determine the contribution of Regulator of calcineurin 1 (RCAN1) that impacts both NF-κB activity in
osteoclasts and Wnt signaling in osteoblasts/osteocytes to the inherently low bone mineral density (BMD) in
DS. The proposed experiments will also determine the impact of cessation of the current clinical bone anabolic
interventions in the setting of DS as well as define DS fracture healing. Aim 1 will elucidate the pathways
through which RCAN1 controls osteoclast and osteoblast differentiation and function. Aim 2 will provide the
first direct evidence of fracture healing and repair in the context of low bone accrual and DS. Aim 3 will
determine the effects of discontinuation of current pharmaceutical anabolic therapies (anti-sclerostin antibody
and intermittent PTH) on bone mass accrual in three preclinical mouse models of DS. The successful
completion of this study will lead to a paradigm shift in our understanding of the DS bone phenotype and a new
landscape of high-quality research that will provide clarification of the mechanisms that contribute to the low
bone mass in DS and more importantly, provide the basis for new directions for the treatment of the fractures
and profound osteopenia that affects this population.

Public health relevance
PROJECT NARRATIVE The long-term goal of this research is to understand bone anabolism, cessation of treatment and fracture repair in the setting of Down Syndrome (DS). These studies will provide important new insights regarding the specific involvement of genes associated with trisomy 21 and the regulation of skeletal homeostasis. The application provides the first ever assessment of fracture repair and the impact of anabolic treatment cessation in DS.